NCI SBIR Contract Topic 428 Phase II (Solicitation Number: BAA 75N91022R00027): Cloud-based Liquid-biopsy and Radiomics Platform for the Cancer Research Data Commons

Integrative analysis of multi-omics datasets is revolutionizing cancer research and patient care. To take advantage of the full breadth of CRDC’s petabyte-scale data, EarlyDx will seamlessly integrate its liquid biopsy cloud-computing platform with CRDC data repositories. Liquid biopsies provide a non-invasive approach for interrogating the genomic and epigenomic profiles of tumors. Co-analysis of CRDC datasets with userprovided data from a tube of blood will ensure broad user adoption of the CRDC. To that end, in Phase I, EarlyDx has developed a prototype that successfully integrates its informatics tools with the CRDC multi-omics datasets through the DCF. The goal of this Phase II project is to finalize the Phase I prototype and expand the prototype to integrate imaging data in the CRDC and implement deep learning tools for integrative multi-omics and radiomics analysis. Specifically, we will conduct the following aims: 1) finalize the Phase I prototype for multi-omics analysis; 2) expand the platform for CRDC imaging data analysis; 3) implement integrative analysis tools; 4) implement diagnostic tools; 5) recruit at least 100 users for usability testing. Our platform with CRDC integration will accelerate cancer research and promote clinical applications such as cancer detection and treatment in broad populations.